Core E: Omics Core

Omics Core Abstract
The Omics Core (Core E), led by Drs. Sid O’Bryant and Mark Mapstone will use advanced methods to conduct
state of the art quantitation of fluid-based biomarkers representing all levels of systems biology; from the genome
to the metabolome for use in the proposed projects and to share with the broader scientific community. We will
derive genomic, transcriptomic, proteomic, and metabolomic information from peripheral blood and
cerebrospinal fluid (CSF) collected from our participants as part of our established clinical protocol. Peripheral
blood is an accessible matrix with only minor risks associated with collection and would be preferred for
translational applications, while CSF is a CNS-specific matrix with high specificity for CNS disorders like AD in
DS. We will employ targeted approaches to quantify known markers from these matrices based on our
preliminary work and we will use untargeted methods to quantify a variety of other potential markers. This
combined approach will provide the highest likelihood of capturing the most valid and reliable fluid-based
biomarkers and a rich dataset for new biomarker discovery by our group and other qualified groups around the
world. The Core is represented by world class scientists with expertise in genomics and transcriptomics (Lee,
Kamboh, Feingold, Cruchaga, Harari), epigenomics (Tycko), proteomics (O’Bryant, Fagan), and metabolomics
(Mapstone, Cheema, Macciardi).